CORE--STATISTICAL AND COMPUTER CORE

The Administrative/Statistical Services Core has three main functions: to facilitate scientific and administrative communication among the Project participants, to manage the central data archives and facilitate exchange of data among projects, and to coordinate statistical services and consultation for the participating investigators. Specifically, it will provide and maintain resources for data management and analysis, serving the three projects and their interactions. The P.I. will supervise the Administrative, Statistical and Computer interactions. In addition, it has primary responsibility for planning, implementation and overall coordination of the interface between the Cores and the five projects. A central database will be constructed to include the following data partitions: Genetic Probe results, Cell Line samples, Cytoarchitectonic measurements, Event Related Potential and Magnetic Resonance Imaging results and aggregated Neurobehavioral measures. Database connectivity is available via a fiber optic link to the University of California, San Diego Super Computer Center, from which satellite bandwidth provides access to each investigator connected to the Internet this Core A has primary responsibility for database maintenance and construction including security precautions and data entry verification.